Genomic Instability as A Driver of Stem Cell Exhaustion

SUMMARY
Stem cell exhaustion is one of the key hallmarks of aging. In tissues throughout the body, there is a
decline in stem cell number and function with age, leading to a loss of tissue homeostasis and
regenerative capacity. Restoring youthful functionality to aged stem cells has been shown to improve
the structure and function of aged tissues. As such, understanding the drivers of stem cell aging has
the potential to reveal targets for rejuvenating tissue and even organismal aging.
Despite the wealth of information on the phenotypic changes of stem cells with age, little is known
about the underlying molecular mechanisms that drive those changes. Among those potential
molecular mechanisms, we have explored genomic instability (another hallmark of aging) as a feature
of aged stem cells. In the proposal, we propose that genomic instability and the accumulation of DNA
damage underlie the age-related decline in stem cell number. Using muscle stem cells (MuSCs) as a
model system, we have reported evidence of increases in DNA damage in aged MuSCs. This
accumulation of DNA damage leads to an increased propensity of MuSCs to undergo a form of cell
death called mitotic catastrophe when they attempt to enter the cell cycle when they are called upon to
repair muscle. We found that this increased risk of cell death is associated with an age-related
decrease in p53 activity, and that stabilizing or enhancing p53 reduces mitotic catastrophe and
promotes muscle repair in aged mice. At the same time, we have found that that ATR, a key mediator
of the DNA damage response (DDR), is highly active in quiescent MuSCs. The primary goal of the
studies of this proposal are to explore the mechanistic relationship between two hallmarks of aging -
genomic instability and stem cell exhaustion.
Toward this goal, we will pursue three independent Specific Aims. In Aim 1, we will explore the role
of p53 in the regulation of MuSC number during aging. We will use gain-of-function and loss-of-function
genetic models to test this hypothesis. In Aim 2, we will examine the role of ATR in MuSC maintenance
with age. These studies will include an unbiased phosphoproteomic screen to determine downstream
mediators of ATR in MuSC maintenance. Aim 3 will focus on a p53 target gene, NDRG1, which has
been shown to regulate genomic integrity in cancer cells under conditions of low proliferative states. In
Preliminary Studies, we have found that NDRG1 slows MuSC activation, which is essential for the
repair of DNA damage prior to cell division. We will examine the role of NDRG1 in MuSC activation
during aging, again using gain-of-function and loss-of-function approaches. Together, these studies will
advance our understanding of stem cell aging and highlight approaches to restore youthful function to
aged stem cells as a way to enhance tissue homeostasis and repair in older individuals.

Public health relevance
PROJECT NARRATIVE Muscle stem cell exhaustion is one of the hallmarks of aging and leads to gradual impairment of tissue structure and function. However, the molecular mechanisms that are linked to the aging process and that contribute to stem cell exhausting have not been defined. The main focus of this proposal is to examine how increases in DNA damage (another of the hallmarks of aging) might lead to MuSC exhaustion, and to explore how the molecular mechanisms that normally limit DNA damage could be enhanced to preserved youthful MuSC structure and function.